AGING--CONFORMATIONAL CHANGES OF COLLAGEN

The conformation of the collagen molecule and the energetics of packing of collagen into fibrils will be studied in order to analyze the geometrical and energetic factors that determine structure and stability. Methods of theoretical conformational analysis will be applied. The assembly of normal collagen will be investigated, in order to understand the role of the chemical composition and of noncovalent interactions between the polypeptide chains in determining the structural organization of collagen. The chemical and mechanical behavior of collagen is altered in aging. Abnormal behavior of collagen in several age-related diseases has been attributed to differences in fibril packing and crosslinking. The purpose of the proposed research is to elucidate the stuctural factors responsible for such alterations, in order to aid the understanding of the chemical and physiological events that are important for collagen function in its normal state and in aged or diseased tissues. The energetics of packing and alignment of triple-helical collagen molecules will be studied as a function of amino acid sequence and hydration, in order to derive a model for fibrillogenesis. Methods derived in this study also will be used to investigate the packing of polypeptide chains in other proteins, such as the collagen-like triple-helical structure in the complement protein Clq of the immune system, the packing of Alpha-helices in bacteriorhodopsin, and the folding of regular structures in globular proteins. Rigidity and conformational stability of various regions of collagen will be compared, in order to establish a correlation with the specificity of enzymatic cleavage. The role of proline analogs, useful in preventing fibrosis, will be correlated with their possibly destabilizing effect on the triple helix. The conformation of nonhelical regions of collagen and its relationship with crosslinking will be studied, in order to analyze the specificity of enhanced crosslinking and its effects on the chemical behavior of the collagen molecule in biological aging.